The Discovery of Molecules and Mechanisms of the Rhomboid Superfamily

Project Summary/Abstract
Elimination of misfolded proteins by ER-associated protein degradation (ERAD) ensures that proteins entering
the secretory pathway are correctly folded and that ER stress is maintained at acceptably low levels. All ERAD
pathways include a protein translocation process termed retrotranslocation, in which ubiquitinated ERAD
substrates are selectively extracted from the ER before degradation by the cytosolic 26S proteasome. Despite
its commonality in ERAD, many features of retrotranslocation have remained mysterious. We have made a major
breakthrough in understanding retrotranslocation. By employing whole-genome yeast arrays, we have
discovered the rhomboid family protein Dfm1 to be critical for the removal of membrane substrates and has
opened the door to a deep mechanistic understanding of retrotranslocation and rhomboid protein biology.
Notably, we identified two additional biological functions of derlin Dfm1 where 1) it employs a chaperone-like role
for alleviating aggregated misfolded membrane protein stress and 2) regulates sphingolipid metabolism. Overall,
this places Dfm1 at the heart of vast membrane-related processes. To gain deeper biological insights from these
new findings, we will:
1) Define the mechanism associated with Dfm1-mediated retrotranslocation.
2) Explore a new stress-state associated with aggregated misfolded membrane proteins.
3) Determine how Dfm1 regulates sphingolipid metabolism.
We will use a multifaceted approach including biochemistry, cell biology, genetics, structural biology, proteomics,
and advanced microscopy to address these central questions in rhomboid proteins and membrane biology. We
will leverage our unique in vivo and in vitro assays-and continue to devise new ones-to dissect the basic
mechanisms of rhomboid-mediated retrotranslocation and its place in cell and organismal biology. A mechanistic
understanding of rhomboid protein biology in protein quality control, stress alleviation, and lipid metabolism will
establish foundational biological insights while unveiling therapeutic targets for a variety of critical pathways
including protein misfolding, protein quality control, ER stress, and lipid dysregulation.

Public health relevance
Project Narrative The rhomboid protein superfamily has been uncovered as regulators of diverse membrane-related processes and defects in rhomboid protein function is associated with Alzheimer’s, Parkinson’s, immune disorders, cancers, and some infectious diseases. Generating new drugs requires knowledge of cellular mechanisms associated with rhomboid proteins. This project will investigate the mechanistic actions of various members of the rhomboid protein superfamily and will aid in developing treatments along with therapies for these diseases.